Texas A&M Center for Environmental Health Research (TiCER)

Data Science Facility Core ABSTRACT
The vision for the Texas A&M Center for Environmental Health Research (TiCER) is to
nucleate research and translational activities of faculty around the overarching theme
“Innovative solutions for addressing exposure-stressor interactions in urban and
urbanizing areas in the state of Texas.” The Data Science Facility Core (DSFC) will
provide key enabling services in data collection, storage, analysis, and integration to
assist members of the Center to fulfill this mission. Key data science challenges that the
DSFC will address include the high dimensionality of novel biological and chemical data
streams, the need to translate data into actionable knowledge for environmental health
decision-making, the need to geospatially contextualize data at the level of local
communities. The DSFC will support these needs by leveraging data science expertise
and resources across Texas A&M. There is a nearly ubiquitous need for such services
across the Center’s two research themes: Stressors to Responses; Environment and
Metabolism. Thus, the DSFC will serve as a key facilitator of interactions across the entire
Center. The DSFC’s overarching goals are to provide novel and state-of-the-art data
science services to support and integrate the Center’s scientific and outreach activities.
This goal will be accomplished by providing services in several specialized and complex
areas of data science— bioinformatics/biostatistics, risk sciences, and geospatial
sciences—as well as providing a central data repository for Center investigators. In the
bioinformatics/biostatistics area, the DSFC will focus on analysis and interpretation of
complex data streams, especially the emergence of single cell-based analyses. In the risk
assessment area, the focus will be on characterizing and predicting chemical toxicity
through both mechanistic and data-driven mathematical/statistical models that integrate
multiple diverse data sets. Furthermore, geographic information systems have emerged
as an essential element of identifying and solving environmental health problems, and
communicating and tailoring policy interventions. DSFC is adding personnel with
extensive experience in geospatial analytics, data integration, and visualization, enabling
it to substantially enhance the impact of Center research in support of communities and
decision-makers. Finally, integration of data will be facilitated through a common data
repository, the design and development of which will be closely coordinated with the rest
of the Center, and which be indexed for searching and data mining. The DSFC will provide
these services through direct support from Core senior personnel and as well as a flexible
staff that can vary in effort depending on needs. The DSFC will work closely with the
Administrative Core to encourage investigators’ use of the DSFC and access and track
the Core’s operation and funding allocations. The leaders of the DSFC have an
established track record of collaborative, interdisciplinary, and translational research, and
are well positioned to support the data science needs across the Center to address
environmental exposures in Texas and beyond.